Selective Modulation of Neutrophils in Critical Illness

Project Summary
Caring for the critically ill accounts for 5-10% of all U.S. healthcare spending, while in-hospital mortality
remains high (20-40%). Yet, there are currently no effective therapeutic interventions beyond supportive care
and antibiotics. The development of new therapeutic strategies requires filling important gaps in our knowledge
of the pathophysiological mechanisms underlying immune dysfunction in the critically ill. Hemorrhagic shock
induces a systemic response that results in immune dysfunction, rendering the host susceptible to severe
secondary infections that are a significant cause of morbidity and mortality in hospital ICUs. The focus of the
research program outlined in this MIRA renewal is in understanding how hemorrhagic shock alters the
response of neutrophils, the essential mediators of acute host defense against bacteria/fungi. When
dysregulated, neutrophils prematurely deploy their antimicrobial arsenal of cytotoxic proteases and reactive
oxidants, directly injuring host tissue. Following hemorrhagic shock, neutrophils become “primed” and
subsequently induce acute lung injury, coupled with a significant deficit in their capacity to find and fight
infection. Our long-term goals are to understand the mechanisms of neutrophil dysfunction that occurs as a
result of hemorrhagic shock and to identify targets for correcting aberrant neutrophil function. Our studies will
interrogate three aspects of the neutrophil response: priming, trafficking, and antimicrobial function. We have
established an innovative approach for the rapid generation of neutrophil-specific chimeric mice by
transplantation of conditionally-immortalized neutrophil progenitor cell lines. Importantly, this technique does
not require animal irradiation and yields robust chimerism of donor-derived neutrophils (>40%) that are
functionally equivalent to endogenous neutrophils. This system is genetically tractable, enabling in vivo studies
into the mechanistic aspects of neutrophil dysfunction following hemorrhagic shock. In Project 1, we will
continue using our clinically relevant “two-hit” mouse model of critical illness through hemorrhagic shock and
secondary respiratory infection. We will determine the mechanisms underlying the dysregulation of specific
subset of neutrophil effector functions (e.g., reactive oxidant generation, degranulation) in response to
hemorrhagic shock, evaluating the role of novel genes in acute lung injury and bacterial clearance. In Project 2,
we will employ our microfluidic platform to investigate the mechanisms of neutrophil sequestration in model
pulmonary capillaries. As the lungs are particularly susceptible to neutrophil-mediated injury, this model
provides a means to evaluate new strategies for modulating aberrant neutrophil trafficking that contributes to
acute lung injury. In Project 3, we will pursue several targets for enhancing the antimicrobial function of
neutrophils without exacerbating injury to host tissue, focusing on methicillin-resistant Staphylococcus aureus.
Together, these integrated approaches will address major knowledge gaps in neutrophil pathobiology by
spanning the molecular, cellular, and organism/disease levels of experimentation.

Public health relevance
Project Narrative The body's systemic response to trauma (severe injury, hemorrhagic shock, etc.) results in compromised immune function. This ultimately results in high susceptibility to hospital-acquired secondary infections and inflammation that damages organs such as the lungs. Neutrophils are the immune system's first line of defense against bacterial infection, but their response can also cause collateral damage to our tissues. Our research uses multiple approaches to understand how hemorrhagic shock alters neutrophil function, with a goal of developing strategies to modulate neutrophils such that they are better able to eliminate infection without causing damage to host tissue.